Administrative Core - Core A

The Administrative Core will act as an enabling-hub for the highly collaborative, synergistic scientific project cores, act to support deep, multidisciplinary training opportunities for our future scientists and to facilitate efficient, and effective dissemination of our work and resources. The core will provide the administrative and organizational resources to foster synergy both between the project cores and with existing departmental initiatives, support training and outreach, and planning and evaluation activities. The director of the center will be Beth Stevens and she work closely with CoPIs, McCarroll and Carroll to ensure the tasks of the center are efficiently delegated and executed in a coherent manner. The team will include a part time administrative assistant, who will assist with operational tasks and an Research Administrator who will be responsible for creating and updating website content, organizing and corresponding with SAB members and symposium speakers. In addition to augmenting interdisciplinary training, the administrative core will coordinate dissemination and outreach work to both to the scientific community and the public, including establishing and maintaining a website, a biannual interdisciplinary scientific symposium (spanning genetics, immunology, and developmental neuroscience) and a biannual meeting for educators and clinicians on youth mental health. The latter will bring together middle school and high-school teachers with care providers including school counselors, mental health social workers, nurses, child & adolescent psychiatrists, and students of these disciplines for a series of talks, workshops and discussion forums on brain development and psychiatric disorder. Finally, the core will spearhead the creation and operation of our platform for resource sharing.